Food Delivery, Remote Monitoring, and coaching-Enhanced Education for Optimized Diabetes Management (FREEDOM)

ABSTRACT
Deep South states, including Alabama (AL) and Mississippi (MS), have the highest rates of type 2 diabetes mellitus (T2DM) and some of the worst outcomes due to T2DM-related cardiovascular disease (CVD) and chronic kidney disease (CKD). Over half of the health differences related to T2DM can be attributed to factors such as reduced healthcare access, limited financial resources, transportation barriers, and food insecurity. There is a need for effective and sustainable intervention packages that address T2DM-related outcomes. Consistent with the Center’s theme (applying a precision public health approach across the care continuum to reduce the burden of cardiometabolic disease), the overall goal of the Food Delivery, Remote Monitoring, and Coaching-Enhanced EDucation for Optimized Diabetes Management (FREEDOM) study (Project 3) is to develop an optimized, multilevel, and scalable intervention to improve T2DM control in low-income adults with T2DM and cardiorenal complications in the Deep South. The FREEDOM study will enroll 304 adults through three health systems in AL and MS. A randomized factorial optimization design using a multiphase optimization strategy (MOST) will evaluate three intervention components: 1) digital health coaching, 2) food box delivery, and 3) remote patient monitoring (RPM). Thus, this project will evaluate multilevel interventions that address changes at the individual (patient), interpersonal (patient-care team communication), organizational (healthcare system–delivered RPM), and community (food box delivery) levels to improve T2DM management among low-income adults with cardiorenal comorbidities (CVD or CKD). Aim 1 will identify the combination(s) of the three intervention components that reduce HbA1c (primary outcome) at 12 months. Aim 2 includes within-trial cost-utility analyses of intervention components. Aim 3 will identify contextual factors that impact implementation of these different interventions using a Consolidated Framework for Implementation (CFIR) approach, and the implementation outcomes will be assessed via the Reach, Effectiveness, Adoption, Implementation, and Maintenance (RE-AIM) framework. This study will leverage multi-healthcare system and healthcare system–industry partnerships to develop optimized, sustainable intervention strategies to improve T2DM outcomes in low-income adults living in the Deep South.

Public health relevance
The mission of the Deep South Center to Reduce Disparities in Chronic Diseases is to develop a regional research center focused on the prevention, treatment, and management of cardiometabolic diseases, including obesity, diabetes, and hypertension, among populations who suffer disproportionately from these conditions in Alabama, Mississippi, and Louisiana. The Center represents a partnership between the University of Alabama at Birmingham, Tuskegee University, Pennington Biomedical Research Center, and the University of Mississippi Medical Center, along with regional non-academic partners to translate and sustain cardiometabolic research in real-world community and clinical settings. The Center is focused on expanding the region’s research workforce, promoting effective bi-directional collaborations between researchers and non-academic partners, and advancing scientific discovery through synergistic research projects focused on multi-level, multi-domain interventions for the prevention, treatment, and management of cardiometabolic diseases in the Deep South.